2024 SoCal Genome Stability Symposium

ABSTRACT
The 2024 SoCal Genome Stability Symposium is a one-day conference that will be held at The
Scripps Research Institute, La Jolla, CA. The conference will focus on the topics of genomic
instability, DNA damage signaling, mechanisms of DNA repair, DNA mutagenesis, environmental
mutagens, cancer etiology and cancer treatment. Understanding the mechanisms in these areas will
not only shed light on the fundamental processes governing the maintenance of genome stability but
will also pave the way for developing new effective cancer treatment. We aim to bring a rigorous
scientific program that fosters the exchange of new research findings and innovative ideas on the
interplay between DNA repair and cancer treatment. We will invite graduate students and postdoctoral
fellows from diverse research laboratories to present cutting-edge unpublished research.
One unique aspect of this conference is that we dedicate the entire program to the trainees,
allowing only graduate students and postdoctoral fellows to give oral and poster presentations. This
creates invaluable opportunities for trainees to gain experience in formal research presentations in a
real conference setting. Additionally, this conference will provide networking and mentoring
opportunities for the career development of young scientists. This conference is free of charge for all
participants, ensuring that every student or postdoctoral fellow from Southern California has equal
access to participate.
The goals and objectives of the conference are: 1) to expose students and postdocs to the
new frontiers of a rapidly progressing research area; 2) to provide a formal platform for presentations
to trainees, and an opportunity to receive feedback on their research progress; 3) to stimulate new
collaborations between laboratories across different research institutions; 4) to catalyze opportunities
for young scientists to network with a diverse group of scientists, including by receiving formal and
informal mentoring and by opening future postdoctoral or faculty position opportunities; 5) to provide
an atmosphere of inclusion and rigor for the trainees participating in the symposium. The symposium
will enhance interactions among students and postdoctoral fellows from all genders, backgrounds,
and origins, including historically marginalized groups such as those from underrepresented racial and
ethnic groups, individuals with disabilities, individuals with different sexual orientations, and individuals
from socioeconomically disadvantaged backgrounds.

Public health relevance
PROJECT NARRATIVE Exploring DNA repair mechanisms will not only shed light on the fundamental processes governing the maintenance of genome stability but will also pave the way for developing new effective cancer treatment. The 2024 SoCal Genome Stability Symposium will focus on research related to genomic instability and its implications in cancer development and cancer therapy. This conference will also provide an invaluable training opportunity for young scientists, aiding their career development in the field of DNA repair and cancer treatment.